Variant Chromatin Structures-Targeting and Functions

PROJECT SUMMARY
My research investigates variant chromatin structures that decorate the chromosomal landscape of eukaryotic
cells, focusing on how these structures are targeted to specific genomic sites and what these structures do in
cells. The bulk of the chromatin consists of canonical nucleosome, which has a core of two H2A, H2B, H3 and
H4 histones wrapped by ~150 base pairs of DNA. However, variant chromatin particles exist, and they create
unique features along the DNA, bookmarking the genome and demarcating functional domains.
One project is centered around the histone variant H2A.Z, which is a prominent landmark associated with
promoters. H2A.Z is required for optimal transcription response and early animal development. But exactly how
H2A.Z modulates transcription is unclear. My lab has made significant progress in understanding H2A.Z’s
targeting mechanism. One breakthrough was the development of a biochemical approach that utilizes native
yeast nucleosomes as a substrate for H2A.Z incorporation. This innovation revealed sequence motifs within
nucleosomes crucial for H2A.Z targeting. Our proposed studies aim to explore the interplay between H2A.Z
and the transcription machinery. We posit that H2A.Z nucleosomes, positioned just downstream of promoters,
serves as a ‘speedbump’ to RNA polymerase, moderating its transition from initiation to elongation. To test
this, we will deploy an array of biochemical and genomic techniques, including a novel in vitro transcription
assay that utilizes native nucleosomes. Our research will extend to examine how H2A.Z’s role in transcriptional
repression within gene coding regions and the interplay between histone modifications and transcription.
The second project investigates the R-octasome, a nucleosome-like particles but with a core made up of four
H3 and H4. We recently solved the cryo-EM structure of the R-octasome and detected its existence in yeast.
However, the biological function of R-octasomes is unknown. Preliminary data suggest that R-octasomes are
associated with the telomeric repeats. Using a mutant that is disruptive to R-octasome formation, our data
suggest that its integrity is important for subtelomeric gene silencing. We hypothesize that R-octasomes are
integral components of telomeric heterochromatin. A combination of genetic and biochemical tools will be used
to pinpoint how R-octasomes contribute to heterochromatin formation. We will interrogate the biophysical
properties of R-octasomes, especially on its role in higher-order structure formation.
Numerous studies have established correlations between variant chromatin structures and genomic functions.
However, pinpointing their mechanistic roles remains challenging. Unlike the histone modification field, where
‘reader’ proteins recognizing histone codes is well established, variant chromatin structures, like H2A.Z, do not
appear to be ‘read’ by conventional recognition domains. Rather, they exert their influence by modulating the
biophysical and biochemical properties of chromatin in a more nuanced way. Our research aims to investigate
variant chromatin structures in the native context and to develop new methodologies to assess their functions.

Public health relevance
PROJECT NARRATIVE Chromatin structure and organization profoundly influence gene expression which ultimately controls normal cell proliferation and cellular differentiation in humans. Mutations in genes functioning in chromatin assembly and remodeling are found associated with numerous human tumors. This grant is focused on understanding unique types of chromatin structures and how these structures are used by the cell to influence genomic activities, such as gene expression, and the outcome of this research could potentially lead to new targets for therapeutic intervention.